The role of high endothelial venules in sex dimorphism in rheumatoid arthritis

Summary/Abstract:
The proposed study addresses the mechanisms of sex differences in rheumatoid arthritis; in particular, we focus
on the high endothelial venules and their roles in female-biased disease development.
Rheumatoid arthritis (RA) is the most common inflammatory arthropathy worldwide, and it is a chronic,
complex, and heterogeneous autoimmune disease. The treatment mainly focuses on suppressing excess
inflammation and slowing the disease progression to minimize joint damage and enhance physical function and
quality of life. There's no cure for rheumatoid arthritis. The complex abnormal regulation of immunity causes
auto-reactive inflammatory reactions, leading to persistent inflammation and articular destruction. RA is a well-
known female-biased disease (3:1 ratio). Women have higher susceptibility, earlier onset, severer symptoms,
and more exacerbated disease progression. Interestingly, juvenile idiopathic arthritis which sex hormones are
negligible, also shows a female-biased disease prevalence, illuminating the genetic predispositions in
rheumatoid arthritis in females. The majority of research focuses on the hormonal influences and dysregulation
of immune cells caused by genetic disposition. Yet, the contribution of the tissue microenvironment to sex
differences has remained elusive. In particular, blood vessels are the most critical gateway for the leukocytes to
migrate into the joint synovial membrane. Research on the blood vessels will uncover the unknown mechanism
for the disease development and female biases in RA.
This project will focus on ectopic high endothelial venules (HEVs), specialized vessels for leukocyte
recruitment which have been found in RA but not in osteoarthritis. HEVs play a critical role in the initiation of
adaptive immunity in secondary lymphoid organs by recruiting naïve leukocytes. Previous single-cell data of
HEVs shows the potential skewed X-inactivation and upregulation of X-linked genes. As a result of dose
compensation at embryonic development, one X-chromosome in females is silenced. However, 15-23% of X-
linked human genes escape from this X-inactivation, causing upregulation of X-linked genes. We will take two
independent approaches to investigate if HEVs and their skewed X-inactivation are the major cause of sex bias
in RA. Aim 1: To identify the skewed X-inactivation and upregulation of X-linked genes in HEVs in human RA.
Aim 2: To perform a proof-of-concept study in animal models to demonstrate the cause of sex dimorphisms.
This proposed project initiates investigating the X-linked genes in HEVs and seeking their potential impact
on female-biased RA progression. The studies will also uncover the X-inactivation and bi-allelic gene expression
in ectopic HEVs. Our new mouse models to perform a proof-of-concept study are useful for future investigation
to examine the significance of skewed X-inactivation in non-circulating local tissues for sexual dimorphisms in
RA.

Public health relevance
Narrative This study will investigate the cause of sex differences in rheumatoid arthritis. The outcome of this study provides fundamental knowledge to understand why females have a high susceptibility to rheumatoid arthritis. This knowledge will help to develop future therapeutic strategies by targeting X-chromosome genes and high endothelial venules.